Multi Union National Worker and Worker-Trainer Health and Safety Training program

Overall HWWT and HDP Project Summary The ICWUC seeks to continue its national multi union training
program to protect a range of collateral duty emergency responders and disaster workers and develop a
cadre of worker trainers by offering 496 classes to 7,258 trainees (HWWT) and 246 classes to 3,657 trainees
(HDP). Our goal is to have active, informed workers and trainers on the front lines of handling toxic
substances to recognize the danger of spills, leaks, exposure to highly infectious agents, disasters and
catastrophic releases, protect themselves and improve their workplaces. To accomplish this, we use a range
of adult education principles and techniques that rely on the knowledge and experiences of the participants
to teach key principles in a non-threatening and engaging method that motivates trainees to improve their
worksites.
We will include two new partners, the American Federation of State, County and Municipal Employees
(AFSCME), the largest public sector union and the Association of Occupational and Environmental Clinics
(AOEC), a national network of experienced occupational health professional with a range of expertise in
chemical and biological exposures and health effects. We will launch a major initiative to conduct Spanish
and bilingual classes and develop bilingual worker trainers to deliver training on a range of disaster hazards.
We will continue to develop worker trainers, offer hazmat classes to industrial, health care, government and
school workers. We will continue our Plume Software and exposure to highly infectious disease classes,
authorize trainers and staff in OSHA classes and continue our work with other NIEHS Grantees.
The ICWUC Center will continue to collect pre and 6 months post-training survey data of participants'
attempts to change their workplaces (which has resulting in two published papers). By comparing this paired
data source for the same individuals, this has indicated that the intervention of the ICWU Center's program
motivates, educates and arms these workers with skills to return to their worksite and make improvements
in site safety plans and procedures. Two other papers documented joint labor/management programs to
train all site workers and track improvements. We will explore the role of worker trainers as site experts
outside the classroom.

Public health relevance
The ICWUC seeks to continue its national multi union training program to protect a range of collateral duty emergency responders and disaster workers, develop a cadre of worker trainers by using adult education principles and techniques, expand Spanish programs and add two new partners, AFSCME and AOEC.